Encoding of inflammatory mediators by vagal sensory neurons

Project Summary
This is the same as the parent award. The nervous system and immune system communicate
with each other to respond to infections and maintain immune homeostasis. Work over the last
two decades has shown that the vagus nerve is a critical pathway for neuro-immune
communication carrying motor signals descending to the body, in addition to sensory signals
ascending to the brain. Detection of immune mediators in the periphery, such as cytokines, is
thought to be vagally-mediated but it is unclear how sensory neurons respond and represent this
information in situ. The goal of the proposed studies is to discover how vagal sensory
neurons encode and represent information about specific inflammatory mediators. This
new understanding will provide crucial mechanistic insights into the nervous system
representation of immune signals, which can be used to understand what goes wrong in a host
of inflammatory disorders that involve immune dysregulation.
With a team of experienced scientists who are experts in the neural regulation of immunity,
we will use genetically encoded calcium indicators to monitor large groups of vagal sensory
neurons while they respond to specific inflammatory mediators. We will use techniques and
tools adopted from neuroscience to determine whether these neurons encode information
using a population code or a temporal code for representing information immune-relevant
information.

Public health relevance
Project Narrative This is the same as the parent award. The nervous system and immune system communicate with each other to monitor and respond to internal changes and outside threats. Inflammatory mediators present in the periphery must be encoded and signaled up to the brain through sensory neurons, but how this neural representation happens is unknown. Using a novel method to monitor vagal sensory neurons responding to these mediators, we will determine how immune-signals are represented by the peripheral nervous system.